Medgar Evers College-Kingsborough Community College Bridges to the Baccalaureate Program

The Medgar Evers/Kingsborough Bridge Program will continue to upgrade an educational
environment and mechanism to increase the number and quality of undergraduate
students completing an Associate Degree in Science who continue to the Bachelor's level
with an ultimate aim of entering a career in biomedical research. The transition period
between completing the A.S. degree and entering into a B.S. degree program can be a
serious stumbling block, impeding the progress of well qualified and potentially successful
students who continue to be grossly underrepresented in the fields of biomedical research.
Our aim is to actively promote the academic success of students from the targeted areas
by providing a five year long intervention and enrichment program using the combined
resources of Medgar Evers College and Kingsborough Community College, both of which
are located in Brooklyn, NY. The program will promote student interest, excitement and
ability to pursue biomedical studies; student awareness of the accessibility of biomedical
careers through continuation of their education; improve student verbal, written,
mathematical and social skills to provide them with the basics to successfully pursue
biomedical careers; promote student realization of the relationships of biomedical studies
to all aspects of their lives because the biomedical sciences are a major driving force in
society; and provide a smooth transition into a senior college for students graduating from
Kingsborough Community College. To achieve this and better prepare students, who will
be the next generation of biomedical researchers, Medgar Evers College and
Kingsborough Community College will continue their academic partnership to improve the
already good relationship, strengthen all meaningful components of our programs and
initiate innovative strategies.

Public health relevance
The Medgar Evers/Kingsborough Bridge Program has direct relevance to public health in so far as it will be a prime education conduit for a future generation of biomedical research scientists. The major components of the project: courses for skills development, research training, research experience and curriculum and methods development, that will be undertaken during the time period of the project are biomedically oriented. The students will be grounded in research training and go on the graduate schools and beyond to become members of the biomedical research workforce.